Clinical Trials and Imaging Core

PROJECT SUMMARY – Core 2
The Clinical Trials and Imaging Core (Core 2) will provide the leadership and expertise needed to support
the clinical research of the three projects. This Core will also focus on evaluating the benefits of adopting the
brain tumor imaging protocol (BTIP) as a standardized imaging acquisition protocol for clinical trials.
Core leadership includes expertise in neuro-oncology, neuro-radiology and clinical trial operations. The Core
will be lead by Dr. Annick Desjardins, Director of Clinical Research at the Preston Robert Tisch Brain Tumor
Center at Duke. She will be joined by Dr. Barboriak, neuroradiologist with a specific research focus in the
evaluation of brain tumor therapies. Dr. Desjardins will interact with the leaders of all three proposed Projects
to successfully conduct the clinical trials. The Clinical Trials and Imaging Core will support the actual
conduct of the clinical trials, including providing clinicians, research manager, research nurses, research
nurse practitioner, clinical trial coordinators, regulatory personnel and data coordinators. Dr. Desjardins
will assure the development, successful conduct and publication of the clinical trials coming from the work of
the three Projects, by assuring the development of all the required documents for the conduct of the study
(for example: protocols, consent forms, clinical side of IND submission, standard of practice
documents), regulatory management, data collection and data publication. Dr. Barboriak will be
responsible for all radiographic assessments obtained in patients enrolled in the clinical trials supported by
the grant, including the assessment of the semi-automated approach (TREXT) to determine if it gives
results to enhance measurement that are comparable to standard clinical read and perform no worse than
the standard approach for prediction of disease status.

Public health relevance
PROJECT NARRATIVE – Core 2 The primary aim of the Clinical Trials and Imaging Core (Core 2) is to facilitate conduct of the clinical trials outlined within this grant and ultimately improve the survival and quality of life of patients suffering from brain tumor. This Core will support the efforts of three Projects offering novel therapeutic strategies for adult brain tumors. The Core will supply clinical and radiologic leadership and input towards those efforts.